Automated Digital Imaging for Cervical Cancer Screening

Project Abstract/Summary:
Cervical cancer screening programs remain essential to reduce cervical cancer in women despite
the availability of human papilloma virus (HPV) vaccines. Screening is important for all women
but is particularly important for women living with HIV given the high prevalence of HPV in this
group and risks associated with progression notwithstanding antiretroviral therapy. Here we
propose to investigate the clinical utility of a new method of automated digital imaging of the cervix
on the MobileODT platform as a screen-and-treat approach. We build on a long-term collaboration
between the University of Cape Town and Columbia University investigating how to strengthen
cervical cancer screening and treatment in South Africa. Currently, screen-and-treat programs
utilizing HPV DNA testing are recommended by the World Health Organization. We have
demonstrated the safety, efficacy and cost-effectiveness of this approach for the South African
setting with its high HIV prevalence in women. In this setting, we are currently completing an NCI-
supported study demonstrating the feasibility and outstanding performance of an HPV DNA assay
that can be used at the point-of-care for a single-visit, screen-and-treat program. Here we propose
to extend this work to investigate in Specific Aim 1: the performance characteristics of automated
digital imaging as a standalone, primary screening test to replace HPV DNA testing for use in the
single-visit, screen-and-treat approach; Specific Aim 2: the performance characteristics of
automated digital imaging as a triage test for women who test HPV DNA positive in the screen-
and-treat approach; and Specific Aim 3: facility-level operational challenges and facilitators to
integrating this new imaging technology into single-visit screen-and-treat programs. We propose
to undertake the studies to address these aims among women living with and without HIV at
clinical sites in Cape Town, South Africa. Our overall goal is to strengthen cervical cancer
screening approaches to reduce cost and improve the effectiveness of screening.

Public health relevance
Project Narrative We propose to investigate the accuracy and implementation potential of a new technology that provides an automated and almost instant classification of cervical cancer precursor lesions based on a cloud-based, machine-learning algorithm of an image of the cervix. We will investigate the clinical utility of this new technology for integrating into screen-and-treat programs for women living with and without HIV in South Africa.